Strengthening Antibiotic Resistance Surveillance in Retail Food Specimens in Kansas as a Part of the National Antimicrobial Resistance Monitoring System

Project Summary
Strengthening Antibiotic Resistance Surveillance in Retail Food Specimens in Kansas as a Part of the
National Antimicrobial Resistance Monitoring System
As a key activity in combating bacterial antimicrobial resistance (AMR), the National Antimicrobial Resistance
Monitoring System (NARMS) since 1996 monitors AMR in foodborne pathogens and indicator bacterial species
in food-animals at the time of their processing; in red meat, poultry, and since 2020 also in seafood products
sold to the public in retail; and in human foodborne infections. The program monitoring AMR in retail food is led
and managed by the Food and Drug Administration – Center for Veterinary Medicine (FDA-CVM). The food
sample collection and microbiologic analysis are performed by the program sites in individual states. The site
in Kansas was established in 2016, and the site-team has performed the NARMS Retail Food Surveillance
programmatic activities of collecting and subjecting to microbiologic and whole genome sequencing analysis
samples of food retailed in Kansas. The actual PIs have taken the leadership of the project and conducted
NARMs in Kansas since October 2023. One of the major innovations in the program in recent years has been
addition of whole genome sequencing and annotation of the bacterial isolates obtained from retail food
samples. We incorporated bacterial isolate identification by MALDI-TOF in October 2023. This new project will
enable the Kansas site-team to continue the prior programmatic activities in Kansas, microbiologic
characterization and routine whole genome sequencing and annotation of bacterial isolates obtained from food
samples collected in retail stores in Kansas as implemented and optimized over the past 5 years.
The isolates, and their epidemiologic and genomic data will be delivered to the NARMS Retail Food
Surveillance program on the required schedule. The program team will use these data and materials to
enhance AMR surveillance and foodborne outbreak analysis and enable program and policy development at
the national level. Epidemiologically relevant AMR information of target bacterial species isolated from food
collected in retail stores in Kansas will be provided semiannually to the Kansas Department of Health and
Environment (KDHE) to advance public health in the state and inform program and policy development.
Additionally, this information will be made available to county and community public health offices upon
request. The data will be also used by our team for educational and outreach purposes throughout the state, to
raise public awareness of AMR. Therefore, this project will strengthen AMR surveillance and analysis, support
foodborne outbreak investigation, inform antimicrobial drug stewardship, and promote public health in Kansas
and nation-wide.

Public health relevance
Project Narrative Strengthening Antibiotic Resistance Surveillance in Retail Food Specimens in Kansas as a Part of the National Antimicrobial Resistance Monitoring System As a key activity in combating bacterial antimicrobial resistance, the National Antimicrobial Resistance Monitoring System (NARMS) has since 1996 monitored resistance in foodborne pathogens and other enteric bacteria of food-animals at the time of animal processing; in red meat, poultry, and seafood sold in retail; and in human foodborne infections in the U.S. The monitoring in food products sold in retail is coordinated by the Food and Drug Administration – Center for Veterinary Medicine. This project will strengthen and ensure continuation of the antimicrobial resistance monitoring in food products retailed in Kansas, which is one of the major food producing states. 1